Leveraging epigenetic and epitranscriptomic aberrations in cancer to identify molecular targets for designing therapy

PROJECT SUMMARY
Myelodysplastic syndromes (MDS) are clonal, heterogeneous disorders caused due to ineffective
hematopoiesis characterized by refractory anemia and erythroid dysplasia. To uncover genes responsible for
dysplastic erythropoiesis in MDS, our group performed methylome analysis of blood cells from MDS patients
which revealed DOCK4 (Dedicator of cytokinesis 4), a guanine exchange factor was significantly hyper-
methylated and under-expressed in MDS. DOCK4 is differentially expressed at various stages of the erythroid
differentiation program suggesting that it has stage-specific functions. Although DOCK4 functions in other cell
types have been described, its function during blood cell development is unknown. Based on this information, I
hypothesize that DOCK4 is an important signaling protein that is instrumental in regulating overall cell shape
and promoting terminal maturation of hematopoietic stem/progenitor cells (HSPCs) into erythrocytes. The
overall goal of my research is to uncover the functional significance of DOCK4 at various stages of
differentiation and elucidating the mechanisms underlying this regulation. In our recent study, I demonstrated
that deficiency of DOCK4 resulted in erythroid dysplasia by disrupting F-actin organization and re-expression
of DOCK4 improved the observed erythropoietic defects. During the remainder of my Ph.D., I will identify
various cellular and signaling pathways deregulated by DOCK4 using primary human CD34+ HSPC derived
erythroblasts haploinsufficient for DOCK4. In addition, I will determine whether modulation DOCK4 pathway by
small molecule drugs can ameliorate the erythroid dysplasia caused by reduced levels of DOCK4 ex vivo using
MDS erythroblasts. Altogether, the outlined studies will conclusively establish the signaling circuits perturbed
by DOCK4 during malignant erythropoiesis and likely to identify novel treatment strategies for MDS patients.
In addition to epigenetic mechanisms, cells possess an extra layer of RNA regulatory mechanisms
where specific bases of the RNA are reversibly and dynamically modified during various cellular processes.
Proteins regulating specific RNA modifications such as N6-methyladenosine and 5-methylcytosine are
deregulated commonly in breast cancer however; the roles of RNA modifications in cancer pathogenesis are
unknown. Therefore, it is of utmost importance to understand how tumors rewire the regulation of RNA
modification mechanisms for their advantage. I want to dedicate my post-doctoral research to elucidate the key
role/s played by specific RNA modifications during cancer development and progression. My proposed post-
doctoral research focuses on studying the dynamic regulation of specific RNA modifications and the signaling
pathways regulating it during breast cancer initiation and progression using genetically engineered mouse
models, cell lines and patient samples. Understanding how tumors disrupt the regulatory pathways and
studying the molecular mechanisms underlying it will potentially lead to novel treatment strategies.

Public health relevance
PROJECT NARRATIVE Better understanding of epigenetic and epitranscriptomic regulation in cancer can lead to novel therapy options. To this end, during my Ph.D., I propose to uncover how epigenetic deregulation of a signaling protein DOCK4 facilitates erythroid dysplasia in pathogenesis of myelodysplastic syndromes (MDS). My proposed post-doctoral research will investigate mechanisms by which specific post-transcriptional RNA modifications are regulated during cancer initiation and progression. The newer insights provided by these studies would not only enable development of novel therapies but also facilitate diverse training for me to become an independent researcher in the field of epitranscriptomics.